Negative regulation of inflammation during Klebsiella pneumoniae infection

Project Summary
Infections with Klebsiella pneumoniae (KP) activate the IL-17 signaling pathway, which is crucial to constrain KP
dissemination and facilitate pathogen eradication. During this process, IL-17 is negatively regulated by RNA
binding proteins (RBP) in an effort to decrease collateral tissue damage in the host. One of these RBPs is
Regnase-1 (Reg1) which degrades IL-17- induced transcripts either through the coding region or 3'UTR. In this
proposal, we will investigate the role of Reg1 in the airway epithelium during KP pneumonia. We hypothesize
that Reg1 deficiency enhances the effect of pro-inflammatory transcripts in the airway epithelium which favors
immunity against KP. For that purpose, we will characterize a Reg1 conditional knockout in the airway epithelium
upon KP pneumonia as well as investigate Reg1 regulation at the epigenetic and post-transcriptional level.

Public health relevance
Project Narrative Interleukin -17 (IL-17), a crucial mediator of immune inflammation is also required to constrain Klebsiella pneumoniae infection. In the process of fighting against this infection, IL-17 induces Regnase-1 (Reg1), which degrades IL-17-proinflammatory transcripts to keep IL-17 in check. In this proposal, we plan to investigate the mechanisms by which Reg1 deficiency enhances immunity to Klebsiella pneumoniae in the lung epithelium as well as how IL-17 induces changes at the chromatin level to promote accessibility at the Reg1 locus.